MULTICENTER NETWORK OF NEONATAL INTENSIVE CARE UNITS

This is an application to become one of the cooperating study centers in the Cooperative Multicenter Network of Neonatal Intensive Care Units (NICUs).